Modulating costimulation in CAR T cells to enhance antitumor efficacy

Project Summary
Innovative adoptive cellular therapies have emerged as revolutionary treatment options for patients with
hematologic malignancies. One such promising strategy, Chimeric Antigen Receptor (CAR) T cell therapy,
involves genetic modification of autologous T cells to express a CAR, redirecting the cytotoxic response of T
cells towards hematologic tumors expressing human B cell maturation antigen (hBCMA) on multiple myeloma
or CD19 on B cell lymphomas and leukemias. While response rates to CAR T cell therapy are strikingly high in
patients with hematologic malignancies, most patients experience disease relapse, highlighting the urgent need
to improve CAR T cell efficacy for a durable response. Preliminary data from our lab and published literature
indicate that targeting endogenous CD28 on CAR T cells is a viable approach to enhance CAR T cell efficacy.
The CAR contains a costimulatory domain (such as CD28), which undergoes activation upon ligation of the
target antigen to the CAR, delivering costimulatory signals to contribute to CAR T cell activation, leading to
subsequent CAR T cell effector functions. Importantly, as the CAR is integrated into T cells, T cells also express
natural endogenous CD28, which can engage CD28 ligands in the tumor microenvironment or on other T cells
themselves, providing yet another source of costimulatory signals that contribute to CAR T cell activation.
Interestingly preliminary data from our lab show that deletion of endogenous CD28 enhances the functional
persistence of CAR T cells in vivo. As such, we hypothesize that endogenous CD28 contributes to the
overstimulation of CAR T cells which increases exhaustion, decreases persistence, and hampers efficacy. To
test our hypothesis, will rigorously evaluate how knockout of endogenous CD28 using CRISPR/Cas9 technology
affects CAR T cell function and efficacy using established preclinical in vitro and in vivo models. These studies
have the potential to identify a novel role of endogenous CD28 in hindering CAR T cell efficacy, while highlighting
a clinically relevant strategy to improve CAR T cell efficacy.

Public health relevance
Project Summary Although Chimeric Antigen Receptor (CAR) T cell therapy has shown remarkably high response rates in patients suffering from hematologic malignancies including B cell lymphomas, leukemias, and myeloma, most patients experience disease relapse, driving the need to identify and understand mechanisms to enhance therapeutic efficacy of CAR T cells. The proposed research will contribute to fundamental understanding of CD28 costimulation in CAR T cells, and specifically how endogenous CD28 found on the surface of CAR T cells impact CAR T cell function, persistence, and efficacy. As CRISPR-modified CAR T cells are currently being evaluated in clinical trials, this research will have clinical implications through the generation of novel CRISPR-edited CAR T cells to enhance efficacy and durable responses.